TAS::75 0850::TAS RECOVERY-BIOMARKER BASED VALIDATION OF DIET AND PHYSICAL ACTIV

This contract supports purchase of supplies needed for the Biomarker-based Validation of Diet and Physical Activity Assessment Tools within existing cohorts study conducted by the National Cancer Institute.